Characterization of P. falciparum gametocyte-essential genes using a novel genetic screen

Plasmodium falciparum, the causative agent of malaria, continues to be a major global burden. Even
today, the vast majority of the parasite’s genome has yet to be characterized. This has greatly hindered our
ability to develop new antimalarials, therapies, and vaccines. This is particularly true of the sexual gametocyte
stage of the parasite, which follows the symptomatic stages in the human host and is transmitted to the
mosquito. Gametocytes are not easily cleared by current drug regimens, allowing transmission to occur even
after treating an infected individual. To date, there have been few ways to study multiple Plasmodium genes at
once, particularly for stages outside of the blood stage. I have worked to develop a new gene editing system
that is both accessible and highly scalable. Using Cas9 base-editing, specific C-to-T mutations can be made to
introduce early terminations using only a gRNA. This system is highly efficient and can be used to knock out
multiple genes in a pooled format. In order to screen for genes essential to gametocyte development, I have
generated a list of 250 genes predicted to be essential for the sexual stage based on transcriptomic
abundance, proteomic abundance, and evolutionary conservation. I hypothesize that these abundantly
expressed and highly conserved genes will be essential to the gametocyte stage, and will incur a fitness
cost when silenced. In order to test this, I will perform a genetic screen with this novel editing system using a
fluorescent marker for gametocytes. Sorting and sequencing of fluorescent parasites will identify
underabundant gRNAs, representative of gametocyte essentiality. The top five hits from our genetic screen will
then be individually knocked out and phenotyped to examine the morphology and impairment on mosquito
transmission. The findings of this proposal will aid in identifying new drug and vaccine targets that could help
prevent the spread of malaria.

Public health relevance
Project Narrative: The sexual stage of the malaria parasite, P. falciparum, remains poorly understood. This project will apply a novel Cas9 editing system for the generation of hundreds of gene knockouts in order to screen for genes essential to the sexual stage. The results of this screen will help further characterize this stage of the parasite while also providing new antimalarial and transmission-blocking vaccine targets.